Perinatal Dysbiosis, Lung Development and Asthma

Environmental exposures that alter asthma risk (C-section, breast feeding) also influence microbial colonization.
Dysbiosis regulates mucosal IL-17A and IL-22 levels differently, reducing IL-22 production while enhancing the
recruitment of IL-17A-producing cells. As IL-22 mediates homeostasis at mucosal surfaces, and IL-17A
production is associated more severe asthma phenotypes, this suggests dysbiosis-induced regulation of asthma
pathogenesis may involve an underappreciated dysregulation of the IL-22/IL-17A balance. Our preliminary data
show that: (1) perinatal dysbiosis induces lung structural changes, increased baseline airway hyperreactivity
(AHR), and exaggerated house dust mite (HDM)-induced asthma phenotype (more severe AHR, elevated
chemokine production, enhanced recruitment of IL-17A-producing cells); (2) organoids derived from dysbiosis-
exposed epithelial cells demonstrate reduced colony forming efficiency and increased HDM-stimulated
chemokine production; (3) IL-17A blockade abrogates perinatal dysbiosis-augmented, HDM-induced AHR; (4)
perinatal IL-22 blockade recapitulates some features of perinatal dysbiosis (increased airway responses and
lung permeability in HDM-naïve adolescent mice); (5) IL-22Ra1 expression is regulated developmentally on
pulmonary mesenchymal cells; and (6) supplementation with acetate reverses perinatal dysbiosis-induced
alveolar permeability. Thus, we hypothesize that perinatal dysbiosis-induced reduction in neonatal mesenchymal
IL-22 signaling drives altered lung development, increased allergen-driven recruitment of IL-17A-producing cells
and more severe asthma later in life, and that bacterial metabolite supplementation will reverse these
phenotypes. This hypothesis will be tested in three Aims: Aim 1: To define mechanisms driving increased
allergen-induced IL-17A-producing cell recruitment and identify the IL-17A-secreting cells driving severe
asthma after perinatal dysbiosis, we will determine if perinatal dysbiosis influences immune cell
responsiveness to chemotactic signaling, identify pulmonary structural cells responsible for increased chemokine
production, and identify which IL-17A-producing ILCs are necessary and sufficient to drive the structural and
asthma phenotypes observed after perinatal dysbiosis. Aim 2: To determine if perinatal IL-22 signaling in
mesenchymal cells influences pulmonary development, baseline AHR, and the severity of allergen-
driven AHR, we will target IL-22-activated signaling pathways in mesenchymal cells during critical neonatal
windows in control mice, and supplement animals exposed to perinatal dysbiosis with rIL-22 or IL-22 producing
cells, and assess the impact on dysbiosis-induced phenotypes, Aim 3: To determine if dysbiosis-induced
alterations in lung development or asthma severity can be reversed by supplementation with bacterial
metabolites, we will test the capacity of bacterial metabolites administered prophylactically and therapeutically
to reverse dysbiosis-induced phenotypes. Collectively, these studies will elucidate the mechanisms by which
perinatal dysbiosis influences asthma development.

Public health relevance
Project Narrative Recent advances have demonstrated that the pattern of microbial colonization at mucosal surfaces can influence the nature and the magnitude of the immune responses at those sites. Decades of human epidemiological data suggest that early life exposures to a variety of environmental insults now known to induce substantial and long- lasting changes to the host commensals (i.e. cigarette smoke, birth by cesarean section, exposure to antibiotics) can influence susceptibility to the development of chronic inflammatory diseases, such as asthma. The long- term goal of the current project is to delineate how key commensal-regulated factors influence the development of mucosal immune system through the life of the host in order to design therapeutic strategies to mitigate the ability of known environmental exposures to influence development of asthma in later life.